DOPEXAMINE AND NITROPRUSSIDE IN TREATMENT OF CHF

The purpose of this study is to assess the combination of the drugs, dopexamine hydrochloride and nitroprusside in the treatment of patients with severe heart failure.